Core-Vector Core

The Vector Core will provide viral vectors to investigators for each research project in the context of this Program Project Grant. The Vector Core will construct, produce and test adenovirus-based vectors. These vectors will be used to express CXCR3 ligands, IL-17, IL-17R-IgG, mycobacterial and Pneumocystis antigens, and ovalbumin (OVA) in the lungs of experimental animals outlined in Projects 1, 2 and 4. The Vector Core will also construct, produce and test recombinant fowlpox viruses (FPV) expressing mycobacterial antigens, CXCR3 ligands and OVA. Recombinant FPV vectors will be used in prime-boost approaches outlined in Projects 1 to 4.